Center for Transformative Infectious Disease Research (CTIDR)

PROJECT 1 PROJECT DESCRIPTION
Our proposed studies will investigate how extreme weather events and seasonal
changes affect risk of spillover of zoonotic infections from bats. Our work will help
identify evidence-based strategies to prevent disease emergence in multiple
ecological settings. Bats are the known or progenitor hosts of four of the nine
diseases identified by the World Health Organization as research priorities. Bats also
may be exquisitely vulnerable to changes in weather because their food resources
are seasonal and physiologically they are sensitive to temperature changes. We will
leverage two long-running datasets on emerging pathogens from bat hosts to
examine the role of weather in driving shedding patterns and spatial behavior of bats
and likelihood of exposures in humans.
Our methods, innovative both conceptually and methodologically, will use already
collected datasets. We will integrate these datasets to move beyond assumptionladen correlations of spillover risk towards mechanistic understanding of how
ecological, environmental, and host-viral drivers of infections influence disease
emergence. Our work sets the stage for remote sensing methods to identify places
and periods to prioritize for prevention of spillover. In Aim 1, we will identify
weather-driven effects on the health of bats, diet, and paramyxo- and corona-,
virus infection dynamics in Australia, using retrospective data collected
previously by the PI. Hypothesis: We will observe higher prevalence of viral
shedding in sampled bats after or during specific environmental conditions (e.g., hot,
dry, then wet conditions, flood, high rainfall) and higher prevalence will be correlated
to markers of bat health, diet and viral infection dynamics. We will use novel
Bayesian multilevel models to analyze these data. In Aim 2: we will investigate
how host space-use changes in relation to environmentally-driven resource
availability and how these changes drive spatial and temporal overlap of bats
and humans. Hypothesis: resource constraints on natural food sources will lead to
increased contact between bats, humans, and bridging hosts.
Our work will lead to strategies, derived from empirical data and modeling, that can help
prevent spillover of pathogens from bats to humans. Preventing spillovers from bats in
any part of the world reduces the risk of pandemics and reduces human mortality and
morbidity in the United States; prevention of spillover is highly cost- effective when
strategies are successful, and can lead to interventions that buffer effects of
environmental change on sensitive species such as bats.